Mechanisms of Cell Polarity Establishment

Project Summary
Cell polarization is of fundamental importance to the morphogenesis of living organisms. Polarized epithelial
cells comprise the foundation for the majority of organs in the mammalian body, and defects in polarity and
intercellular junctions are responsible for multiple diseases of the kidney, skin, and intestine. A deep
knowledge of epithelial morphogenesis is essential, therefore, to understanding the development both of
normal tissues and of many human diseases. The PAR proteins are key components of the polarity machinery
and interact with other polarity proteins, such as CRUMBS, PALS1, and atypical protein kinase c (aPKC).
Some of these factors play important roles beyond those associated with polarity, including cell division and
survival. In previous funding periods we made substantial contributions to the current understanding of cell
polarity complexes and their functions. Recently, several interactions with membrane transport factors have
been uncovered, illuminating a long-suspected link to polarized vesicle transport. Nonetheless, the molecular
mechanisms coupling polarity proteins to vesicle traffic are still not well understood.
In this project, we will exploit new technologies in gene-editing and microscopy to investigate with
unprecedented resolution vesicle tethering at the plasma membrane and its regulation by PAR polarity
proteins, apical membrane formation, and novel factors involved in this process. Using CAS9 gene-editing, we
have created multiple epithelial cell lines that express functional, fluorophore-tagged alleles of the endogenous
exocyst subunits, exocyst regulators and multiple polarity proteins, using both mouse mammary epithelial cells
and human induced pluripotent stem cells (hIPSCs). Analysis of these lines by multi-channel total internal
reflection fluorescence microscopy (TIRFM) or near-TIRF (HILO) imaging, and quantitative mass spectrometry
(MS) will enable the resolution of long-standing questions about the regulation of exocyst and polarity complex
dynamics. Because CRB regulates apical size and is a key regulator of HIPPO signaling, its concentration at
the apical membrane must be closely regulated, but the mechanisms for this control are not understood. We
developed a new assay to study apical protein dynamics, using a fusion of GFP-binding peptide (GBP) to the
extracellular domain of CRB3. Addition of recombinant GFP rapidly tags this protein. We exploited this system
to perform a genome-wide CRISPR knockout screen to identify factors that regulate apical CRB3 localization.
Candidate proteins, and known factors such as the polarity proteins PAR6 and aPKC will be functionally
analyzed using HILO imaging and a system to synchronously release CRB3 after trapping it in the ER.
Together these studies will provide important new insights into the connections between vesicle traffic and the
cell polarity machinery.

Public health relevance
Narrative Most tissues in the body are composed of epithelial cells, which have a surface that faces outwards into the environment, and one that faces inwards. This property is called polarity, and defects in polarity contribute to multiple human diseases. Our project is to understand the fundamental mechanisms of epithelial cell polarity, using sophisticated microscopy and gene editing techniques, and this new microscope will greatly facilitate the accomplishment of this goal in a timely fashion.